DOSE ADJUSTMENT OF BUSULFAN IN BMT FOR CHILDREN WITH AML OR INBORN ERRORS

This is a study to determine whether there is increased engraftment along with decreased severe toxicity following a BMT when a specific busulfan concentration at steady state is administered during the conditioning phase of treatment.